Inteins: Expanding Biological Roles and Biotechnological Applications

PROJECT SUMMARY/ABSTACT The long-term goals of this application are to better understand the biological importance of inteins as post- translational regulatory elements, their emerging role in pathogen stress response, and to harness the power of their unique chemistry to invent useful technologies for the biomedical research community. Inteins, or intervening proteins, are self-catalytic, mobile genetic elements removed from host genes through protein splicing. From the applied perspective, the ability of inteins to shuffle peptide bonds in highly specific ways has proven exceptionally useful in protein engineering, leading to the development of numerous technologies. While intein applications have dominated their investigation, and new intein-based technologies are developed frequently, the biological importance of inteins in nature is poorly understood. Inteins are abundant mobile genetic elements in the microbial world, found in approximately one-half of archaea and one-quarter of bacteria. Contrary to long-standing assumption that inteins are molecular parasites, mounting recent evidence suggests that some intein-containing proteins have evolved to couple splicing, and thus host protein activation, to environmental signals. This represents a novel and potentially widespread form of post-translational regulation. Further, given inteins are absent in humans and located within essential genes of several pathogens, understanding the environmental factors that regulate protein splicing inform possible antimicrobial development. We propose the following two aims, building upon recent discoveries, as well as expanding into new arenas. Aim 1 will for the first time investigate the role inteins play as nascent chains, broadly determining whether splicing is possible prior to release from the ribosome, as well as examining possible stress response strategies of bacterial and fungal pathogens. Aim 2 seeks to develop two novel intein-based technologies. First, a general strategy to improve expression of misfolding-prone proteins in bacteria and second, a zinc- controlled self-removing protein purification tag for use in both bacterial and mammalian systems. Through these Aims, this work will enhance our understanding of the roles these exciting and understudied elements play in nature, their role in pathogen stress response, and will lead to new intein-based technologies for protein engineering.

Public health relevance
PROJECT NARRATIVE Inteins, or intervening proteins, are mobile genetic elements found within essential proteins of several devastating human pathogens, including Mycobacterium tuberculosis. Due to their unique ability to rearrange peptide bonds, inteins are also important tools in biotechnology. The overall goals of this application are to discover novel mechanisms by which inteins act as environmental stress sensors and to develop new intein- derived applications for protein engineering.